A Continuing Education Intervention to Address Ableism Among Obstetric Clinicians Providing Perinatal Care

PROJECT SUMMARY
The notion that disabled people would seek pregnancy and motherhood defies long-held social norms
and is fraught with echoes of the eugenics movement of early 20th century America. Nevertheless, pregnancy
and parenthood are increasingly common among disabled people. Despite the increasing numbers of disabled
women having babies, obstetricians often have little training in how best to provide high quality care to this
diverse population, documented through perspectives of both obstetric clinicians themselves and women with
disabilities. Disabled women often experience worse maternal and child health outcomes than their
nondisabled peers. Barriers to optimal care include lack of training and disability knowledge of obstetric
clinicians; lack of professional guidelines for providers; provider unwillingness to care for women with
disabilities; inaccessible equipment and facilities, poor communication, and ableist attitudes and practices
among obstetric health care providers and staff. Furthermore, emerging research suggests that ableist and
discriminatory experiences in reproductive care may disproportionately affect disabled women of color.
Research, both with disabled women and obstetricians, has identified recommendations for improving care,
however, the critical next step have yet to be taken – designing an educational intervention to address these
concerns and prepare obstetricians to provide inclusive care.
This study will develop an online continuing education program for practicing obstetricians that
addresses ableism and structural ableism in perinatal and postpartum care. The study will first conduct focus
groups and key informant interviews to identify essential content and optimal approaches for educating
providers about mitigating ableist attitudes, practices, and policies, structural access barriers, and providing
perinatal care to a diverse population of disabled patients. Based on these findings, the study team will design
an online continuing medical education program and conduct a randomized controlled trial with 200 obstetric
providers. Participants will complete assessments prior to training, and at three- and 9-months following
completion. The study will measure change in ableist attitudes and clinical policies and practices. Knowledge
acquisition, satisfaction with course content, and usability will similarly be evaluated. We will also interview 20
participants about their experiences and revise the program accordingly. We will collaborate with the American
College of Obstetricians and Gynecologists (ACOG) to disseminate the final program to practicing
obstetricians. This project directly addresses priorities identified by the funding agency to develop and test
interventions at a community or health systems level to mitigate adverse health effects of ableism and
structural ableism. The expected outcome of this project is an innovative educational intervention to improve
provider knowledge to mitigate ableism in perinatal care.

Public health relevance
PROJECT NARRATIVE There is an urgent need to address the deleterious effects of ableist practices and policies on the pregnancy-related experiences and outcomes of women with disabilities. While research shows that women with disabilities are as likely to choose pregnancy and parenthood as their nondisabled counterparts, they have a significantly higher risk for adverse maternal and child health outcomes driven by barriers to appropriate care, stigma, and inadequate provider training. This study will develop an online continuing education program for obstetricians with the goal of increasing the timely provision of evidence- based, inclusive perinatal care to women with disabilities.